NATURAL HISTORY, PREVENTION AND TREATMENT OF RECURRENT VIRAL HEPATITIS B &C

To determine the natural history and effectiveness of long term HBIG with or without coadministration of the nucleoside analog lamivudine in persons with hepatitis B following orthotopic liver transplantation.To determine the progression of recurrent Hepatitis C with or without interferon alpha in persons following orthotopic liver transplantation.